Kentucky's Application for MFRPS, Dietary Supplements, Food Protection Task Force, and Special Projects

Kentucky Department for Public Health-Division of Public Health Protection & Safety
Food Safety Branch
Project Summary/Abstract
RE: Flexible Funding Model-Infrastructure Development and Maintenance for State
Manufactured Food Regulatory Programs (U2F) Clinical Trials Not Allowed (Funding
Opportunity Announcement (FOA) Number RFA-FD-23-027).
The goal of this project over the 2023-2026 three-year Period of Performance is to maintain
our agency’s full conformance with each of the 10 Manufactured Food Regulatory Program
Standards by continuing to actively participate and advance state/federal efforts for a
nationally integrated food protection system. Previous Cooperative Funding Agreements since
2011 have allowed our agency to build and maintain a quality state program for the
regulation of our manufactured food industry. In addition to MFRPS
maintenance/conformance, this project will utilize Cooperative Agreement funding to
expand our current regulatory foundation incorporating Dietary Supplements as part of our
Manufactured Foods Regulatory Program.
In an effort to better prioritize and direct our regulatory activities at reducing foodborne illness
outbreaks, our agency further intends to maintain and expand the framework and network
relative to our Food Protection Task force. Funding under a Special Projects add-on will also
be utilized to enhance our current food manufacturing database to enable quicker access to
inspectional information along with bidirectional data sharing. In order to enhance
responsiveness in terms of reducing food safety risks and prevention of foodborne outbreaks,
data sharing with our FDA partners will promote faster communication relative to violative
conditions observed during manufactured food firm inspections.
Continuing our agency’s partnership with FDA under this Cooperative Agreement is essential
for building a solid regulatory foundation, maintaining and sustaining consistency in our
agency’s inspectional approach, supporting a framework aimed at reducing foodborne illness,
and contribute to projects which support and enhances an IFSS.

Public health relevance
Kentucky Department for Public Health-Division of Public Health Protection & Safety Food Safety Branch Flexible Funding Model-Infrastructure Development and Maintenance for State Manufactured Food Regulatory Programs (U2F) Clinical Trials Not Allowed (Funding Opportunity Announcement (FOA) Number RFA-FD-23-027). Project Narrative: The intended outcome of this Cooperative Agreement Funding Application for the 2023-2026 Period of Performance is to maintain and further advance efforts for a Nationally Integrated Food Safety System (IFSS) by utilizing available FDA funding assistance to allow The Kentucky Department for Public Health-Division of Public Health Protection and Safety-Food Safety Branch’s Manufactured Food Regulatory Program to maintain full conformance with the Manufactured Food Regulatory Program Standards (MFRPS). This funding will allow the MFRPS program to maintain current staffing levels (including a MFRPS Coordinator), recruit and retain a highly trained/qualified inspection team, review and update program SOPs, assist our federal (FDA) partners in establishing a uniform basis for measuring and improving the performance of manufactured food regulatory programs, and enhance our Regulatory Foundation to ensure that Kentucky’s Manufactured Food Regulatory Program develops and maintains best practices for a high-quality regulatory program. Kentucky’s continued with these program standards will help Federal and State programs better direct their regulatory activities at reducing foodborne illness hazards in plants that manufacture, process, pack, or hold foods.